Altered pH in early Alzheimer's disease detected by creatine chemical exchange saturation transfer MRI

Alzheimer’s disease (AD) is the most common cause of dementia and, currently, there are more than five
million people with AD in the US alone. The etiology of Alzheimer’s disease is unknown, and therapies are just
starting to be developed. The accumulation of neurotic plaques (Aβ) and neurofibrillary tangles (NFT), as well
as widespread gliosis, loss of synapses, and degeneration of neurons are the major histopathological
hallmarks of AD. However, a diagnosis of AD in the early stages of dementia cannot be determined simply by
the amyloid imaging, because many healthy older adults with brain Aβ deposits never develop dementia in life.
Therefore, additional markers that can provide more accurate information of neurodegeneration, particular at
the early stage, are needed.
Cerebral pH regulation is crucial for cell functioning, enzyme activity and protein folding and pH status
provides information that pertains to cell viability and neuronal degeneration. Previous studies reveal that
abnormal cerebral pH has an important role in the aggregation of Alzheimer’s associated proteins. Some
studies also indicate that the reduced intracellular cerebral pH is a consequence of neuroinflammation involved
in the development of AD, which is an early event in the AD patients and can be detected in MCI subjects,
even when amyloid deposition is not detectable. Hence, in vivo assessment of cerebral pH could be a useful
early biomarker for the differentiation between AD and healthy controls.
Chemical exchange saturation transfer (CEST) MRI is a novel versatile technique that can achieve
enhanced sensitivity and spatial resolution on the standard clinical scanner by exploiting the exchange of
protons between water and various metabolites. Since the proton exchange rate is affected by cellular pH,
CEST MRI can also be utilized to map pH in vivo. Our exciting preliminary data show that the exchange of
protons between water and guanidinium protons from creatine (Cr) CEST is highly sensitive to pH change and
the pH differs significantly between AD and wild type mice measured by CrCEST. Our long-term goal is to
develop a clinically translatable CrCEST based MRI scheme that can non-invasively detect cerebral pH in the
early-stage AD brain with much higher sensitivity than other MRI methods. To assess its potential, we here
propose to verify this approach on mouse AD models. In order to achieve this goal, we have set the following
aims: Aim 1: To identify spatiotemporal dynamics of pH changes in the AD mouse brain and to determine
whether pH reduction progresses with disease and correlates with neuroinflammation.
Aim 2: To assess the pH distribution at the cellular level in the AD mouse brain with the in vivo two-photon
fluorescence microscopy.

Public health relevance
Neuroinflammation is an early event in the Alzheimer’s disease patients, and in vivo assessment of cerebral pH change introduced by neuroinflammation could be a useful early biomarker for AD. The proposed study is to develop and optimize novel, sensitive and potentially widely available MRI techniques to characterize the pH change in brain. The technique is achieved through a novel MRI contrast mechanism, creatine chemical exchange saturation transfer, and will be verified on Alzheimer’s disease animal models.